Research Collaborative for Family Caregivers of Older Adults

Family caregiving for older adults is increasingly recognized as an impending public health crisis due to our
growing aging population and changing family characteristics. To achieve innovative solutions for the grand
challenges family caregivers face, academic entities, who have formerly operated separately, must coalesce to
share research approaches and expertise. The purpose of this K07 application, led by Dr. Lee Ellington, is to
build the Research Collaborative for Family Caregivers of Older Adults at the University of Utah and Utah
Health Sciences to ultimately support the health and wellbeing of family caregivers caring for older adults. The
Collaborative is designed to transcend traditional academic boundaries using a bridging infrastructure to
harness, connect and amplify existing strengths of five campus entities joining for the first time. These entities
include the Center for Alzheimer’s Care, Center on Aging, Center for Health Outcomes and Population
Equity in Cancer, Consortium for Families and Health Research, and the College of Nursing (5Cs). Each is
committed to starting new endeavors and expanding existing partnerships for caregiving science of older
adults through Collaborative activities. Each brings a unique cadre of researchers, trainees and junior faculty,
and has a distinct domain or focus that allows for rich cross-fertilization. In addition to collaborating with the
5Cs, Dr. Ellington will partner with a strong, existing University mentorship program to select and provide
value-added mentorship and training to 10 Caregiver Scholars fostering their potential to become leaders of
interdisciplinary research teams improving support for family caregivers of older adults. Finally, she will create
new caregiving-related curricula, which will be delivered through CCTS and the Interprofessional Education
Program. These curricula streams will have a wide reach at the University and Health Sciences, educating and
training both emerging researchers and the next generation of health care professional about caregiving for
older adults. Drawing from her current leadership experiences and enhanced by additional professional
development activities, Dr. Ellington is poised to achieve the following aims: 1) Leverage existing entities
across the University of Utah and Utah Health Sciences to establish an environment for interdisciplinary faculty
to share, collaborate, and advance research for family caregiving across mental and physical health conditions
and disabilities for older adults; 2) Partner with an established mentorship program at the University of Utah
and Utah Health Sciences to expand capacity and training to promising junior caregiving scientists who actively
participate in Collaborative programmatic activities; and 3) Develop and evaluate new curricula on family
caregiving for older adults to reach new investigators including emerging clinician scientists and future health
care providers. The Collaborative will increase the pool of investigators and promote the capacity and quality of
research; thus, elevating the University’s commitment to caregiving and aging science for the health and
wellbeing of caregivers of older adults for our state, our region and our nation.

Public health relevance
K07 Project Narrative With the number of U.S. family caregivers shrinking and the demands on their health and wellbeing increasing, we are facing a family caregiver public health crisis. By connecting new and established interdisciplinary researchers, we can spark new and innovative solutions for the benefit of family caregivers and their care recipients. This K07 Academic Leadership Career Award proposes to formalize connections and promote collaborations across disciplines and academic entities at the University of Utah and Utah Health Sciences to provide the necessary infrastructure, mentoring, content and methodologic expertise to improve the support of family caregivers of older adults.